Investigating IQGAP1, a scaffold protein, in liver biology and Hepatocellular Carcinoma to overcome barriers in in vivo models

Hepatocellular Carcinoma (HCC) is the 5th most common cause of cancer-related death with an estimated
32,000 annual deaths in the United States. Current measures to combat the disease are insufficient and there
is an unmet need translating pre-clinical model findings to patients. Recently, though, a study modeled HCC in
mice using hydrodynamic tail vein injections with the Sleeping Beauty transposon system (referred hereafter as
the “transposon system”). Here, tumors that develop are 69% genetically similar to patient HCCs driven by
mutant ꞵ-catenin and the tyrosine kinase receptor MET (B+M). I found that including IQGAP1, a scaffold
protein known to orchestrate and promote oncogenic signals, accelerates B+M HCC development and causes
enhanced tumor growth and severity. Importantly, I found increasing IQGAP1 expression promotes YAP1
signaling and drives the expression of NUAK2 kinase, a druggable YAP1 target gene recently linked to HCC
oncogenesis. These findings indicate that targeting the IQGAP1-YAP1 network in the liver could be a possible
direction for future therapies. I aim to better understand how IQGAP1 regulates the molecular mechanisms in
HCC, and my central hypothesis is that IQGAP1 drives HCC oncogenesis and its incorporation into a
humanized HCC system will improve HCC disease modeling. I will test this hypothesis in 2 specific aims:
Aim 1 will establish a humanized model of HCC and determine if IQGAP1 exacerbates disease pathology. Aim
2 will validate the utility of the humanized HCC model by targeting oncogenic Hippo signaling driven by
IQGAP1 overexpression.
Overall, this proposal aims to explain IQGAP1’s mechanistic role in HCC biology. The IQGAP1-YAP1
relationship provides a novel direction for personalized medicine in HCC. In addition, elevated NUAK2
expression resulting from IQGAP1 mediated YAP1 activity is a mechanism novel to my work. Better
understanding this mechanism will provide greater insight to activated YAP1 in HCCs. In addition, my
proposed humanized HCC model is intended to accelerate pre-clinical findings and open the door to potential
personalized therapeutic approaches to benefit patients. I plan to pursue this work during my independent
career and the University of Pittsburgh provides a suitable environment for me to carry out my designed
studies. HCC is a significant public health concern and I am committed to a career studying the disease. With
full support from my collaborators, I am confident that I will be able to complete the proposed research. My
proposal builds on my current expertise and the protected time provided by the K22 mechanism will enable me
to gain experience in techniques that will inevitably support my independence.

Public health relevance
Project Narrative Hepatocellular carcinoma (HCC) is the most common primary liver cancer, and a better understanding of the molecular mechanisms driving HCC will improve therapeutic developments. My proposal investigates an understudied mechanism in HCC I recently discovered where IQGAP1, a scaffold protein, promotes oncogenic YAP1 signaling. Additionally, I propose the engineering of a humanized HCC model; which can be applied to study various oncogenes, and used as a tool to validate and test precision based therapies.